Duke Women's Reproductive Health Research Scholars

Project Summary/Abstract
The long-term goal of the Duke Women’s Reproductive Health Research (WRHR) K12 program is to improve
women’s reproductive health through developing cohorts of obstetrician-gynecologist (Ob-Gyn) clinician-
scientists with the skills to be outstanding independent researchers, leaders, mentors, and communicators. The
program is part of a complementary group of career development programs for women’s health researchers led
by faculty in the Department of Ob-Gyn. Research in the Department encompasses the full range of conditions
included in Ob-Gyn practice along the continuum of biomedical research, from discovery of causal mechansims,
translation of discoveries into interventions, testing those interventions for safety, efficacy, and effectiveness,
through implementing effective interventions into practice. Faculty mentors use a full range of innovative methods
across all of these areas, including laboratory-based research, observational research, clinical trials, and data
analytics and mathematical modeling. A large portion of research opportunities for Scholars focuses on
conditions where there are marked disparities in outcomes, with much of the research specifically focusing on
developing strategies for reducing those disparities. Duke WRHR Scholars develop skills across five Core
Competencies: Responsible Conduct of Research, Grantsmanship and Scientific Communication,
Research Design and Methods, Data Management and Analysis, and Leadership, Mentoring, and Team
Science. These competencies are developed through two to five years of working on defined research
projects with a mentor team, and active participation in program-related meetings, coursework, and other
career development activities. The individualized mentoring includes science-based training, as well as
development of broader skills specific to a career in academic Ob-Gyn through inclusion of senior Department
faculty as Career Mentors and one-on-one work with a physician executive leadership coach. Progress in
achieving the core competencies is assessed based on completion of specific requirements and milestones
adapted individually for each Scholar with their mentor team and WRHR leadership, and reviewed regularly by
our Advisory Committee. Ongoing programmatic evaluation is performed through feedback from Scholars,
mentors, and the Advisory Committee, and formal external review. Our three Scholars to date have been highly
productive as researchers, publishing high-impact work in gynecologic cancer, contraception, and maternal
morbidity, and have numerous grants in review. The Program has been significantly enhanced by the recruitment
of senior funded faculty experienced in both laboratory-based and observational research, and a restructuring of
the Department’s research administration infrastructure. The structured training program, availability of a diverse
pool of experienced mentors using a wide range of approaches and methods, and significant institutional
commitment will allow the Duke WRHR to continue to develop the next generation of leaders in women’s
reproductive health research.

Public health relevance
PROJECT NARRATIVE Conditions affecting women’s reproductive health have a significant impact on quality-of-life, overall health, and life expectancy for both women and their children. Reducing this impact through improved prevention and treatment requires researchers with a fundamental understanding of the clinical impact of these conditions and the ability to apply rigorous, innovative methods to facilitate discovery and translation into effective interventions. The Duke Women’s Reproductive Health Research career development program combines cutting-edge research experiences with an innovative and proven career development framework to help develop the next generation of obstetrician-gynecologist clinician-scientists.